CONTEXT-DRIVEN PROCESSING AND ITS PERSONAL CONSEQUENCES

The general purpose of the proposed research program is to examine the impact of the context of the perceiver on perceivers' interpretation and retrieval of information about themselves and others. The program of research represents a systematic effort to investigate when and why individuals use different constructs in social information processing at different times, and the social cognitive consequences of such context-dependent variation. A series of experiments is proposed to investigate both the effects of and mechanisms underlying the activation and use of social constructs as a function of contextual priming and contextual adaptation: (1) the effects of contextual priming (or construct activation) on the relative accessibility of a person's different self-concepts, and the consequences of such accessibility for a person's mood; (2) the mechanisms underlying the effects over time of both recent and frequent contextual primining; (3) the effects of people adapting their interpretation and/or recall of information about a stimulus person to suit their momentary context when the context changes over time; and (4) the mechanisms underlying the social cognitive consequences of different kinds of adaptation. A number of new middle levels models concerned with "context-driven" aspects of processing will be proposed, and the accuracy of their predictions compared to alternative models will be experimentally tested. These models have implications for understanding the errors in judgment and memory that occur as a result of contextual factors--erros that can impair interpersonal relations and mental health. The program of research has special significance for identifying factors involved in the etiology and treatment of emotional problems.